Prostate inflammatory lesions as a proving ground for development of aggressive prostate cancer

Project Summary: Epidemiological and pathological studies have implicated lifestyle, microbial, and
environmental factors in prostate cancer etiology/risk. A potential link between these factors and prostate
carcinogenesis is the presence of chronic inflammation associated with atrophy (PIA) in prostates of aging
men. Yet, there is a paradox surrounding the role of the immune response in prostate cancer: “the
inflammation paradox”. On one hand, inflammation may be a driver of carcinogenesis. On the other, the
immune system is known to seek and destroy cancer cells. The majority prostate cancer lesions are “immune
deserts”, and ICIs are ineffective in most cases. Why is there an evidently strong immune reaction in non-
neoplastic regions in PIA, but a lack of a robust immune response in most prostate cancers? We hypothesize
that chronic inflammation in PIA represents evidence of an innate immune response that drives
carcinogenesis. However, in this inflammatory “proving ground”, only cells that can epigenetically
switch off this response can emerge to become aggressive neoplastic precursors. We hypothesize that
the paucity of immune infiltrates and lack of PD-L1, is evidence that prostate cancer cells develop a number of
different mechanisms that evade anti-tumor adaptive immunity. We postulate that additional cell non-
autonomous immune suppressive mechanisms enable disease progression. We propose 3 synergistic
Research Projects (2 basic,1 translational) to mechanistically test key questions stemming from our “proving
ground” hypothesis. In Proj 1 (Basic Science) we hypothesize that the STING induction in PIA drives acute
and chronic inflammation, leading to cell injury/cell death and proliferation. Second, in a subset of PIA cells,
epigenetic silencing of STING dampens of the immune response, allowing them to emerge as overt pre-
neoplastic cells. We will test this in animal models and in translational studies employing annotated and
molecularly characterized prostatectomies. The combination of PTEN loss and MYC copy number gain is an
independent predictor of poor outcome in prostate cancer. We hypothesize that the combination of MYC and
PTEN stimulates a cell non-autonomous immune evasion mechanism induced by the recruitment of immuno-
suppressive myeloid cells, and fibroblast activation protein (FAP)-positive fibroblasts. Proj 2 (Basic Science)
will test these hypotheses in animal models and in human tissues. Recently introduced imaging technologies
have raised the hypothesis that PET/CT imaging results may be able to predict molecular and tumoral micro-
environmental characteristics of aggressive prostate cancer. PET imaging for PSMA using PyL PET/CT has
been FDA approved for imaging high risk men prior to prostatectomy. In Proj 3 (Translational) we employ
PET/CT scanning for PSMA and combine this with mpMRI to address these hypotheses. Also in Proj 3 we will
apply newly developed/developing PET imaging agents to non-invasively and longitudinally study the extent of
M2 macrophages and cancer associated fibroblasts in our mouse prostate progression cancer models.

Public health relevance
NARRATIVE Prostate cancer is the most common serious cancer diagnosed in men in the United States, and a leading cause of cancer mortality. This proposal is focused on understanding whether prostate cancer emerges from inflamed regions of the prostate, and in the process, gains the ability to evade the immune system. Through this research we will identify new ways to prevent and intercept the development of aggressive prostate cancer.